Modern Analytics to Improve Quality & Outcome Assessments Following Congenital Heart Surgery

Congenital heart defects (CHD) are the most common birth defects, impacting ~1 in every 100 births. While
surgical outcomes have improved over time, morbidity and mortality remain high for certain lesions, and
significant variation exists across the ~120 U.S. congenital heart centers. This has heightened the scrutiny of
congenital heart programs, with several national high-profile reports leading to program closure and several
quality improvement initiatives to improve national outcomes. All such initiatives depend upon rigorous
measures of program quality, but how best to measure and report quality remains controversial and
understudied. Several features of CHD data and current analytic methods complicate quality assessments. 1)
CHD is a widely heterogeneous, sparse mix of different lesions. Current approaches combine all CHD
surgeries together for quality reporting and adjust for risk based only on operation type and few general
factors, despite the important influence of other routinely collected variables. Machine learning approaches are
better able to incorporate these high-dimensional clinical data but remain understudied, and current methods
rely upon outdated regression. 2) Preliminary studies suggest wide variability in the types of CHD treated
across hospitals, yet differences in hospital case-mix have not been quantified and are not used in quality
reporting. Approaches to assess hospital case-mix distributions could provide an improved understanding of
which hospitals treat comparable patients and which patient subsets are large enough to allow meaningful
quality assessments but have not been studied. 3) Current methods support only indirect assessments of CHD
program quality, prohibiting direct comparisons of interest and ignore important sources of uncertainty, leading
to inaccuracies in the quality estimates. A causal inference framework could support more direct and clinically
relevant quality comparisons across hospitals but has not been investigated. In response to NOT-HL-19-712,
we propose to apply contemporary statistical approaches to address these challenges. Aim 1 will optimize risk-
adjustment using machine learning approaches to characterize operative morbidity and mortality. Aim 2 will
identify overlapping and unique CHD patient subgroups across hospitals to improve characterization of hospital
case-mix and enable valid hospital comparisons. Aim 3 will develop robust hospital quality estimates that will
support direct and clinically relevant quality comparisons across hospitals using causal inference approaches,
focusing on areas of overlap, and including hospital random effects to account for currently ignored sources of
uncertainty. Our methods will be applied within the STS Congenital Heart Surgery Database which captures
clinical information >90% of U.S. congenital heart hospitals and validated in an external source, the Pediatric
Cardiac Critical Care Consortium (PC4) Registry. These advancements will support national initiatives to
improve quality and outcomes for children and families impacted in CHD and will also provide a framework that
can be applied broadly to improve quality assessment across other fields.

Public health relevance
NARRATIVE: Congenital heart defects (CHD) are the most common birth defects, impacting ~1 in every 100 births and while patient outcomes have improved over time, morbidity and mortality remain high for some children, and significant variation exists across the ~120 U.S. congenital heart hospitals. Using a clinical registry containing detailed clinical data from virtually all U.S. congenital heart hospitals, we will apply Bayesian machine learning within a causal inference framework to best utilize the diversity of the data to improve CHD surgical quality assessments. Our proposed research will support national initiatives to improve quality and outcomes for children and families impacted in CHD and will also provide a framework that can be applied broadly to improve quality assessments across other fields.